A consortium effort to translate therapies for neurological diseases via an ex vivo organotypic platform

Project Summary/Abstract
Disorders of the brain remain an enormous medical challenge. New platforms that allow functional testing in
high-fidelity systems that incorporate patient tissue and high-throughput capacity are urgently needed to bridge
gap between cell-based assays and whole-animal testing. We propose a multi-institutional effort to identify,
develop, and initiate translation of therapeutic neurological agents using the organotypic brain slice culture
(OBSC) platform. Our OBSC models leverage existing cellular and extracellular milieu in the live brain slices to
allow rapid, functional testing on brain tissue. Our multi-disciplinary team, which spans three CTSA Program
hubs (UNC, Duke, and Univ. Florida), has developed multiple models for neurological disorders and shown the
effectiveness of the OBSC platform to discover new mechanisms of disease and identify new therapeutic
compounds. We have developed technological innovations for OBSC modeling, including elevated-throughput
techniques for brain slicing, viral- and biolistic-based transduction of disease-relevant genes, targeted gene
knockdown, real-time monitoring using reporter assays, and incorporation of fresh patient tissue. We now seek
to leverage the power of the OBSC platform and experience of our team to broaden the utility of the OBSC
platform and ultimately improve the care for patients suffering from brain disorders. Our multi-institutional team
will bring together and share new disease models, curated panels of therapeutic agents, unique molecular tool
kits, and clinical patient tissue. Within the areas of neurodegenerative disease, brain cancers and ischemic
disease, we will add disease-relevant capabilities to the platform, screen therapeutic agents, and enable new
immune-based approaches, the fastest-growing area of clinical research, with a particular focus on the brain
microenvironment. Approaches to accomplish our aims are: (i) We will use OBSC models of neurodegenerative
disease to develop methods for tracking of cell signaling using real-time optical imaging, define molecular
pathways mediating inflammatory drivers of disease, and identify effective new therapeutic agents. (ii) We will
use fresh patient biopsy samples and OBSC models of aggressive brain cancer to characterize he cellular and
genomic heterogeneity of brain tumors, the efficacy of anti-cancer immune therapies, and perform drug screens
to identify new therapeutic agents. (iii) Lastly, we will utilize OBSC models of ischemic disease to develop
methods for pooled molecular screening, investigate the impact of microglia on stroke progression, and identify
new compounds that reduce infarct size. Together, our approaches will create an expandable infrastructure built
around OBSC technology, accelerate the discovery of new and effective therapeutic strategies, and initiate
translation towards ultimate human patient trials to treat multiple disorders of the brain.

Public health relevance
Project Narrative Disorders of the brain remain an enormous medical challenge and new platforms that serve as functional bridges between cell-assays and animal testing are needed to improve our understanding of the disease and to develop and translate therapeutic approaches towards human patient trials. In this proposal, our interdisciplinary team from three CTSA Program hubs (UNC, Duke, and U. of Florida) seek to advance discovery and translation of therapies for brain disorders by further developing the organotypic brain slice (OBSC) platform. Using our OBSC models of neurodegenerative disease, brain cancer, and stroke, we will develop new technological innovations to add disease-relevant capabilities to the platform, screen therapeutic agents to develop better treatment options, and enable immune-based approaches to target new aspects of disease, all with the goal of advancing accessibility of the novel OBSC model and improving the outcomes of patients suffering from brain disorders.